Cooperative dysfunction of thalamocortical and cerebellar inputs to the auditory cortex in 22q11.2 deletion syndrome model of schizophrenia.

Cooperative dysfunction of thalamocortical and cerebellar inputs to the auditory cortex in 22q11.2
deletion syndrome model of schizophrenia.
ABSTRACT
Altered neural circuit function most likely underlies schizophrenia (SCZ)-related psychosis. One enigmatic
symptom of SCZ is auditory hallucinations, which comprise 85% of all hallucinations in SCZ. The risk of SCZ is
30-fold greater in persons with 22q11.2 deletion syndrome (22q11DS). In murine models of 22q11DS, we
showed that the auditory cortex (ACx), which is implicated in auditory hallucinations, has abnormal activities
(e.g., sound-like neural ensemble firings during silence) that are rescued by antipsychotics. We also identified 2
brain structures related to auditory perception that are affected in 22q11DS: the auditory thalamus, which fails
to send sufficient information about external sensory information to the ACx via thalamocortical (TC) projections,
and the paraflocculus (PF), which projects to the ACx but is substantially smaller in people and mice with
22q11DS than in the general population and wild-type (WT) littermates, respectively. We characterized the
mechanisms of disrupted glutamatergic transmission at TC projections in 22q11DS mice. Haploinsufficiency of
the 22q11DS gene Dgcr8 and upregulation of dopamine receptor Drd2, a target of antipsychotics, mediate this
deficit. However, basic knowledge about the PF–ACx circuits and the mechanism of their dysfunction in 22q11DS
are unclear. Preliminary data show that Purkinje cells (inhibitory neurons) in the PF fire less in 22q11DS models,
causing disinhibition (hyperactivity) of glutamatergic neurons in the deep cerebellar nuclei, the major output of
the cerebellum. Thus, imbalanced auditory thalamus–cerebellum interactions may converge onto the ACx and
cause abnormal hallucination-like neuronal activity. Our new preliminary data show that the PF reaches the ACx
via at least 2 polysynaptic pathways: 1 targets the primary ACx (A1 area) via the lemniscal pathway, and the
other targets the secondary ACx (e.g., AuV area) via the nonlemniscal pathway. We also show that PF
abnormalities are linked to haploinsufficiency of another 22q11DS gene Tbx1. Here we will test the hypothesis
that the dysfunction of PF–auditory circuits and TC circuits underlies abnormal ACx activity and psychotic
symptoms in 22q11DS. In Aim 1, we will test if mimicking 22q11DS abnormalities (i.e., reducing thalamic output
and increasing cerebellar output) causes abnormal ACx activity and psychosis-like behavior in mice. We will also
test if enhancing thalamic output and reducing cerebellar output restores ACx activity and normal behavior in
22q11DS mice. For this, we will use the chemogenetics approach. We will also test if the heterozygosity of Dgcr8
and Tbx1 is sufficient to replicate abnormal ACx activity and psychosis-like behavior in 22q11DS mice. In Aim 2,
we will elucidate and validate the PF–auditory system connectivity in WT and 22q11DS mice to determine if the
PF reduction/dysfunction alters inputs to the auditory thalamus and ACx, thereby contributing to abnormal
auditory processing and perception. Results of these experiments will suggest a new direction for developing
therapeutic interventions by restoring TC communication and reducing abnormal cerebellar activity in those with
22q11DS.

Public health relevance
Relevance: The mechanisms underlying the psychotic symptoms in schizophrenia are mostly unknown. We will use mouse models of 22q11.2 deletion syndrome, a disorder that increases the risk of schizophrenia by 30 fold, to test the sufficiency and necessity of thalamic- and cerebellar-input abnormities to cause irregular neuronal activity in the auditory cortex and psychosis-like behavior.